Neuronal activity-responsive DNA repair mechanisms and cognitive aging

Project Summary:
Accumulating genomic damage to neurons is a cardinal feature of Alzheimer’s disease and the normal aging
process. Although cognitive stimulation has been shown to attenuate the debilitating effects of Alzheimer’s
disease on brain function, stimulus-dependent neuronal activity also poses an inherent risk to genomic stability
across the long lifespan of central nervous system (CNS) neurons insofar as activity-driven transcriptional
responses proceed via the transient induction of local DNA double-stranded breaks (DSBs), which must be
repeatedly repaired. DSB accumulation is an early feature of Alzheimer’s disease. Yet, the extent to which these
Alzheimer’s disease-associated breaks represent unrepaired sites of activity-induced DSBs, and whether
postmitotic neurons employ distinctive repair mechanisms to maintain genomic integrity in the face of these
challenges, remain unclear. In the course of investigating features of the neuronal activity-dependent
transcriptional program, we uncovered a biochemical coupling of neuronal activity to DNA repair mechanisms.
We find that a novel form of the NuA4 chromatin remodeling/DNA repair complex assembles around the
neuronal-specific activity-regulated transcription factor NPAS4 at activity-responsive gene regulatory elements
in the mouse brain, with NPAS4:NuA4 disruption leading to local defects in DNA repair, increased genomic
instability, and shortened lifespan. To gain further insight into the nature of these recurrent neuronal activity-
induced DNA break/repair mechanisms and their contribution to Alzheimer’s disease- and aging-associated
cognitive decline, we propose: 1) to map the landscape of activity-induced DSBs in wild-type mice and mouse
models of Alzheimer’s disease, 2) to assess the contribution of stimulus-induced neuronal DSBs to age-
associated genomic alterations, and 3) to characterize the specialized DSB repair mechanisms active in human
postmitotic neurons with the hope of finding inhibitors or activators of the repair process that might ultimately
serve as starting points for the development of therapeutics for treating Alzheimer’s disease. The proposed
studies will thus provide new insights into the distinctive DNA repair systems active in CNS neurons, clarify the
contribution of recurrent neuronal activity-induced DNA breaks to Alzheimer’s disease- and age-associated
genomic instability, and ultimately provide new opportunities for the development of therapeutic strategies to
combat Alzheimer’s disease.

Public health relevance
Project Narrative: Accumulated neuronal DNA damage is thought to contribute to age-associated cognitive decline and neurodegeneration. The proposed study investigates the molecular mechanisms by which neurons repair genomic damage stemming from repeated neural circuit activation throughout life.